Mode of Action of Environmental Toxicants

DESCRIPTION (provided by applicant) Oregon State University (OSU) in Corvallis is a land-, sea-, and space-grant institution. OSU, with a long history of excellence in environmental health sciences research, has partnered with Oregon Health and Sciences University (OHSU) to provide a comprehensive and interdisciplinary training program for pre- and postdoctoral students in environmental health sciences. OSU is home to a NIEHS-funded Center a newly awarded Superfund Basic Research Program as well as the prestigious Linus Pauling Institute (LPI). These centers and institutes, with their associated facilities and services cores, provide outstanding opportunities for research and training in an environment that heavily favors collaborative programs. The NIEHS Training Grant at OSU, along with the associated OSU centers and institutes, has experienced significant institutional commitment over the years, which further enhances training opportunities on the OSU campus. Additionally, the Training Grant faculty members have active extramural research programs which are reflected in their individual research grant funding. OHSU is home to the medical, dental and nursing schools as well the Vollum Institute and the Center for Occupational and Environmental Toxicology (CROET), both with a focus on neurology, neurotoxicity and degenerative diseases of the nervous system. OHSU is also is home of a Clinical and Translational Science (CTSA) and the Human Investigations Program (HIP) training program. Over the past grant cycle there has been increased integration between OHSU and OSU. The top applicants to the Department of Environmental and Molecular Toxicology and associated graduate programs are aggressively recruited as pre-doctoral trainees, and postdoctoral trainees are recruited through national searches. An important goal of these recruitments is the achievement of diversity among qualified candidates. The productivity of the Training Grant's trainees is solid, and alumni of this training program are currently occupying important positions in academia, government, and industry. Over the next funding period, the training program will be further fine-tuned to improve what is already an outstanding program. There will be a greater emphasis on postdoctoral training with exciting new training opportunities in translational research. The primary goal of the proposed training program is to produce future leaders in the environmental health sciences. Relevance: For diseases with environmental or unknown etiologies there is a pressing need to more rapidly apply basic research discoveries to protect and improve human health. This proposed training program will develop the next generation of post-veterinary health scientist uniquely qualified to apply aquatic-based studies in multi-disciplinary environments to advance human health.